Early Phase Clinical Research Support

Early Phase Clinical Research Support funds are requested to cover a portion of the cost, in the form of salary for one research nurse, of the infrastructure necessary to support the conduct of high priority, innovative, phase I and investigator-initiated clinical research protocols. This infrastructure is essential to insuring regulatory compliance and protocol adherence for trials that are inherently complex and labor-intensive. These trials are critical to our pursuit of the translational objectives of our Center; they have insufficient industry sponsor funding and do not yet have sufficient feasibility and preliminary data to obtain external peer-reviewed funding.

Public health relevance
One of the most important aspects of an NCI-designated cancer center is its involvement in early phase, investigator-initiated clinical research. This component of the JCCC Cancer Center Support Grant will provide funding to support and advance these trial types.